Advanced Course on Cancer-related Health Disparities Research, Mentoring, & Leadership

The overarching goal of the Utah Advanced Course on Cancer-related Health Disparities Research,
Mentoring, and Leadership is to provide innovative, state-of-the-art, evidence-based career development
experiences to faculty participants to enhance their skills in cancer disparities research, leadership, and
mentoring. Our long-term goal is to enhance the training of a workforce to meet the nations’ biomedical,
behavioral, and clinical research needs that will culminate in the reduction of the burden of cancer across
various communities in the United States. We bring expertise in cancer-related databases, culturally tailored
behavioral interventions, mentoring, and leadership training. Our specific aims are:
Aim 1: To recruit and select qualified cancer focused researchers into the Utah R25 Program. We will
prioritize early-stage faculty and faculty for whom cancer disparities is a new area of research.
Aim 2: To introduce participants to cancer-related databases, such as SEER, SEER-Medicare, and “big
data” such as the Utah Population Database (UPDB) and the All Payer Claims Database (APCD) to
investigate cancer-related health disparities. With more states adopting APCDs and large databases
linkages, this training will provide the participants a competitive edge in developing cancer disparities grants.
Aim 3: To train participants on culturally tailored behavioral interventions as well as community-engaged
research approaches to reduce cancer-related health disparities. We will use a combination of 1) didactic
and 2) project design studios to provide participants with impactful interactive experiences for enhancing
their knowledge and skill for incorporating culturally specific behavioral interventions into their research.
Aim 4: To enhance the mentoring skills and strengthen leadership capacity of cancer researchers
through interactive evidence-based educational experiences. We will use a combination of in-person and
novel educational technologies to provide participants with effective mentor training in areas such as building
effective mentoring teams and providing culturally aware mentoring. The leadership training will be an
interactive and experiential program on assessing leadership style in order to manage conflicts, improve
communication, handle negotiations, and become high performance researchers.
Aim 5: To evaluate the Utah Advanced Course on Cancer-related Health Disparities Research, Mentoring,
and Leadership.
Opportunity and Potential Impact: The Utah R25 Program addresses a critical gap in the cancer
academic workforce by equipping faculty with advanced career development experiences. Successful
completion of the goals of the Utah R25 program will lead to the infusion of an additional cadre of 125 well-
trained faculty, thus expanding the capacity to reduce the burden of cancer-related health disparities in
communities across the United States.

Public health relevance
NARRATIVE The overarching goal of the Utah Advanced Course on Cancer-related Health Disparities, Mentoring, Leadership is to provide innovative, state-of-the-art, evidence-based career development experiences to faculty to enhance their skills in cancer disparities research, mentoring and leadership. We bring expertise in mentoring and leadership training through the National Research Mentoring Network (NRMN), culturally tailored behavioral interventions, and cancer-related databases including population-databases that are unique to Utah.